IGF::OT::IGF IMPROVE COMPLETENESS OF TREATMENT AND OTHER KEY DATA ELEMENTS BY LINKAGES WITH 15-MONTH RESUBMITTED DATA FROM COMMISSION ON CANCER (COC) HOSPITALS.

The extent to which obtaining data from CoC hospital resubmissions at 15 months post-diagnosis would meaningfully impact the completeness of treatment or other data required by SEER is unknown. The detailed human and information technology (IT) resources needed to complete the resubmission and updating process is also unknown. The following objectives will be explored using complete diagnosis year 2014 case data resubmissions from CoC hospitals obtained 15-months after December 30, 2014. Objectives: 1) Note and utilize lag times from diagnosis to start dates of specific treatments (i.e., surgery, radiation, therapy, chemotherapy, and hormonal therapy biological response modifiers/immunotherapy, hematologic transplant and endocrine procedure, and other treatment and their corresponding data items) to determine percentage of treatment modalities with start date 6 months after diagnosis. 2) Note the percentage of treatment updates obtained from the 15-month data resubmission from None, Unknown, or Blank to a known treatment code by type of treatment for selected cancer sites. 3) Note the percentage of changes from “Not Otherwise Specified” (NOS) to a more specific treatment code by type of treatment for selected cancer sites. 4) Note the percentage of stage and site-specific factor updates obtained from the 15-month data resubmission from None, Unknown, or Blank to a known stage code for selected cancer sites. 5) Obtain information used for 15-month retransmission and forward it to corresponding CoC hospital registries.